Chromatin contacts are germline-transmissable vehicles underlying epigenetic transgenerational inheritance

Studies in animal models linked gestational exposures to endocrine disrupting chemicals (EDCs) with the
onset of disease in exposed and unexposed descendants. Many groups found such transgenerational effects
of chemical exposures, which were proposed to be examples of epigenetic inheritance. Transgenerational
effects of environmental exposures have substantial support in the literature. Yet the concept that responses to
environmental exposures can be transmitted to subsequent generations through the germline without DNA
mutations remains controversial because the underlying mechanisms have not been explained satisfactorily.
Understanding how effects of environmental exposures are transmitted to unexposed generations without DNA
mutations is a fundamental, unanswered question in biology. We developed a highly reproducible animal
model for transgenerational inheritance of obesity. When pregnant F0 mouse dams were treated with
environmentally-relevant (nM) doses of TBT via their drinking water throughout gestation, increased fat
accumulation was detected in F1-F4 generation male descendants. Affected TBT-group males developed a
transgenerational “thrifty phenotype”: they were resistant to fat loss during fasting, rapidly gained weight when
dietary fat was increased and retained this fat even after being returned to a normal, low-fat diet. Our published
and preliminary results led us to propose a new model for transgenerational inheritance - that prenatal TBT
exposure altered higher-order chromatin structure (HOCS), changing secondary epigenetic modifiers that
inhibited expression of insulin degrading enzyme (Ide) causing diet-induced hyperinsulinemia and obesity.
Here we propose a comprehensive series of experiments designed to determine exactly how exposure of
pregnant F0 dams to TBT alters HOCS in F1-F3 primordial germ cells (PGCs), why these changes are
inherited, rather than reversed to the normal state, how these changes affect lower-level epigenetic regulators
controlling expression of Ide and why does the phenotype only occur in males. Aim 1 will identify mechanisms
that drive changes HOCS near the Ide gene and how these interact with lower-level epigenetic regulators to
modulate Ide expression in the adult liver. Aim 2 tests whether epigenetic interventions, such as dissolving the
HOCS alterations or releasing Ide expression from repression in PGCs or adults can prevent or reverse the
transgenerational predisposition to male-specific metabolic phenotypes. Deciphering the underlying
mechanisms will have profound implications for how the field views transgenerational inheritance and how
future experiments are planned and conducted. This new understanding will be critical to explaining the
etiology of non-communicable diseases such as obesity and type 2 diabetes, targeting their causes and
ameliorating their effects. Our results will have broad implications for understanding epigenetic transmission of
the effects of environmental stressors and could offer opportunities to incorporate considering prevention of
transgenerational inheritance into risk assessment paradigms.

Public health relevance
Obesity is a major public health problem. We propose to elucidate how the effects of prenatal obesogen exposure are transmitted, leading to a transgenerational predisposition to obesity. The successful completion of this research will make important contributions to understanding epigenetic transgenerational inheritance, how obesity is transmitted down the generations and will provide insights into how obesity can be prevented and the obesity pandemic curtailed.